A new class of wet AMD therapeutics

ABSTRACT
Advanced neovascular age-related macular degeneration (AMD) is characterized by choroidal
neovascularization (CNV), in which neovessels originating from the choroid invade the macula. CNV causes
permanent central blindness if left untreated and is the most sight-threatening pathology of AMD. The present
application will investigate the efficacy and regulatory mechanisms for a new class of CNV therapeutics. Anti-
VEGF therapies are the standard of care for CNV and can preserve central vision if administered on an
indefinitely recurring basis but have reached their therapeutic threshold. Moreover, these therapies are costly
and must be injected intravitreally, increasing the risk of complications and patient noncompliance, and limiting
availability of treatment to economically disadvantaged patients affected by disparities in health care delivery.
The present application has the potential to identify new therapeutics and druggable targets for CNV,
particularly those that can be administered systemically rather than intravitreally, and are thus more accessible
to underserved populations.

Public health relevance
PROJECT NARRATIVE Choroidal neovascularization (CNV) is the most sight-threatening complication of age-related macular degeneration (AMD), and current therapies leave 50% of CNV patients legally blind at their therapeutic threshold. This proposal will identify a new class of therapeutics for CNV, which target newly identified mechanisms of disease, and have the potential to be more effective than existing interventions.